Organellar pH shifts in Alzheimer's disease from simulation & experiment

DESCRIPTION (provided by applicant): It is unclear where within brain neurons (which organelles) the amyloid-ß peptide (Aßx) is predominantly produced in Alzheimer's disease (AD) & whether or not the overproduction of Aßx that occurs is due to a mistrafficking/misrouting of the amyloid precursor protein (APP) &/or the ß-secretase enzyme that processes APP in AD. In AD, there is cerebral acidosis (e.g., pH 6.6) & a decreased intracellular pH.1 Since ß-secretase has an acidic pH optimum, it is important to determine if the intracellular acidosis also leads to decrease in the pH of organelles within which APP is processed. The Aims of the proposed work are to (1) gain a molecular level understanding from computer simulations of how changes in the lumenal pH of crude organelle models (liposomes) impact the Aß42 self-aggregation & Aß42-lipid interactions, to (2) establish the baseline pH distribution of the early & late endosome (LE), lysosome (LY), & Golgi apparatus (the organelles within which Aßx is potentially produced) within embryonic & adult mouse brain neurons as a function of (a) each organelle- type's proximity to the cell body, to (3) characterize how these distributions change in a transgenic mouse model (5XFAD) of familial Alzheimer's disease (FAD) as a function of (b) the age of the mice & (c) gross brain region (hippocampus & isocortex) when compared to controls, & to (4) characterize how the colocalization of APP, Aßx, & ß-secretase changes within these organelles with respect to a, b, & c. Aim (1) will be achieved using coarse-grained molecular dynamics simulations of liposomes with encapsulated Aßx. Aims (2)-(4) will be achieved using fluorescence microscopy techniques. The proposed work is driven by the following Hypotheses: (1) a decreased pH will promote self-aggregation of Aßx & interactions of Aßx with the liposome walls, leading to disruption of the integrity of the liposome. (2) The pH distribution of neuronal organelles in all non-AD cases will exhibit a spatial gradient in which the organelles proximal to the cell body will be more acidic than distal organelles. (3) As the 5XFAD mice age, there will be (i) acidosis of the Golgi & early endosomes (EEs) & (ii) a statistically significant increase in th colocalization of Aßx & the ß-secretase enzyme in the Golgi & EEs as compared to the LEs & LYs in the AD model. Changes (i) & (ii) will both appear in neurons of the hippocampus before appearing in neurons of the isocortex. The proposed work seeks to bring the NIH's NIA one step closer to its goal of understand[ing] the nature of aging & the aging process, & diseases & conditions associated with growing older as it relates to AD, a ruthless, currently unstoppable, worldwide epidemic.

Public health relevance
PUBLIC HEALTH RELEVANCE: This research is relevant to public health because Alzheimer's disease (AD), a growing epidemic worldwide, is the primary cause of dementia in the elderly, yet there is not even a single disease modifying treatment clinically available. This project seeks to go back to the basics by characterizing one of the fundamental properties of neurons, organellar pH, in healthy neurons & in those riddled by AD. In addition to the immediate insights gained from the above characterization, this research would help to inform those reading the extant AD literature regarding whether or not results obtained from studies that used immortalized cell lines are or are not truly applicable to the pathophysiology of AD, & it would help inform future researchers about making appropriate cell line choices.